NIH Comparative Medicine Resource Director's Meetings

Project Summary/Abstract
This submission requests finances to organize the 14th Comparative Medicine Resource Center
Directors' Conference (CMRCD) in 2024 and then conferences in 2026 and 2028. These
conferences offer a forum for Directors of Resource Centers funded by the National Institutes of
Health (NIH) Office of Research Infrastructure Programs (ORIP), Division of Program
Coordination, Planning, and Strategic Initiatives. The discussion and action items deriving from
these conferences identify opportunities and challenges that Resource Directors face in
administering and innovating resources in support of biomedical research. The Scientific
Steering Committee will set the agenda for each conference. Tentatively, conferences will
include a keynote address by a prominent Resource Director or NIH funded scientist,
presentations by ORIP-funded scientists and NIH staff, moderator-led discussions, and a poster
session. The first conference for this cycle of funding will be held in Rockville, MD, at the Hilton
Washington DC/Rockville Hotel & Executive Meeting Center for two days on August 6 & 7, 2024.
Rockville offers the advantage of proximity to NIH and thus more significant participation of NIH
staff and scientists in the conference for those who can attend in person. The site and agendas
of successive biennial conferences will be determined after the first conference.

Public health relevance
Project Narrative The National Institutes of Health (NIH) Office of Research Infrastructure (ORIP) supports novel research that improves and protects human health by awarding grants to support research resources, such as animal models for human disease and state-of-the-art biomedical instrumentation. This grant will fund three conferences over five years to bring together the Directors of Resource Centers supported by NIH/ORIP, Division of Program Coordination, Planning, and Strategic Initiatives. The conferences’ objectives are to provide a setting for Directors to discuss common issues and problems pertinent to accomplishing the mission of ORIP, obtain feedback and advice from NIH staff and scientists, and share ideas for common solutions.